Administrative Supplement for R01AR080687

ABSTRACT
Oxidative stress plays a key role in the pathogenesis of osteoarthritis (OA), contributing directly to tissue
breakdown as well as to chronic pain. Attempts to boost antioxidant defenses in the joint have been clinically
disappointing - conventional small molecules and exogenously delivered antioxidant enzymes are plagued by
poor stability and bioavailability, as well as rapid joint clearance following intra-articular injections. To address
these limitations, our parent R01 engineers manganese dioxide nanoparticles (MnO2 NPs), or “nanozymes”, that
mimic the reactive oxygen species (ROS) scavenging functions of antioxidant enzymes, but have significant
advantages in terms of stability, cost, and bioavailability. Indeed, we demonstrated the properties of these
nanomaterials can be tailored for joint tissue retention and cell uptake, which is important for addressing critical
barriers to therapeutic delivery in OA. The parent R01 focuses on optimizing the antioxidant activity of the MnO2
NPs, interrogating their chondroprotective and anti-inflammatory mechanisms in vitro, and evaluating their
disease-modifying ability in vivo in a rodent model of PTOA. This supplement expands on these studies to include
comprehensive evaluation of pain mechanisms in response to MnO2 NP treatment, with particular focus on
neuropathic pain. OA patients can experience a combination of nociceptive and neuropathic pain. With
nociceptive pain, tissue damage and inflammation leads to activation of nociceptors and pain transmission.
Neuropathic pain, however, is caused by damage to the nerves themselves, which can occur with joint injury or
as a result of structural changes in the joint as OA progresses. Treatment of neuropathic pain is challenging, as
commonly used anti-inflammatories are ineffective, and therapeutic options are limited by risk of addiction and
serious adverse effects. Oxidative stress in known to trigger and maintain neuropathic pain, by inducing damage
and mitochondrial dysfunction in nerves.
Given their pronounced antioxidant functions, stability, and
bioavailability, we hypothesize that MnO2 NPs will be effective at alleviating neuropathic pain in PTOA. To lay
the groundwork for this scientific direction, this supplement aims to characterize the antioxidant functions of
MnO2 NPs with neural cells in vitro, and evaluate biomarkers for neuropathic pain in vivo in response to treatment
with MnO2 NP in a PTOA model. These biomarkers, such as joint innervation patterns and cellular composition
of the dorsal root ganglion, will complement the behavior analyses, biochemical analyses, and histopathologic
analyses in the parent R01. This comprehensive assessment of OA pathogenesis, in terms of joint structure,
function, and pain mechanisms, may facilitate successful preclinical to clinical translation of this or other
antioxidant strategies for musculoskeletal diseases and chronic pain.

Public health relevance
NARRATIVE Osteoarthritis (OA) is a debilitating, degenerative joint disease for which there is no cure or effective therapy. Oxidative stress plays a key role in the degeneration of joint tissues, damage to the sensory nerves, and development of chronic pain; however, it has remained an elusive therapeutic target. This research explores a new class of antioxidant nanomaterials that overcomes the persistent challenges faced by conventional antioxidant molecules, and focuses particularly on how it alleviates chronic pain mechanisms in the OA.